1/1 NADIA U24 Administrative Core

ABSTRACT
1/1 U24 NADIA ADMINISTRATIVE CORE - SUMMARY
This is the second renewal of the Neurobiology of Adolescent Drinking in Adulthood (NADIA) Administrative
Core (NADIA Administrative Core-U24, RFA-AA-20-004). The Administrative Core provides organizational and
scientific leadership to achieve the goal of our Consortium: to elucidate persistent changes in complex brain
function-behavior relationships following adolescent alcohol exposure. Adolescent binge and extreme drinking
are common, and while many factors contribute to human brain development and alcohol use during adoles-
cence, animal models are critical for understanding the specific consequences of alcohol exposure on the
brain and behavior during this crucial developmental period. In the previous funding periods, the NADIA
discovered that adolescent intermittent ethanol (AIE) led to multiple behavioral, neurochemical and
physiological patholo-gies in adulthood. Mechanistic studies revealed that these AIE-induced changes could
be prevented or re-versed by targeting specific neurotransmission, neuroinflammation, or epigenetic regulation
of genes. The Consortium has been very productive, as evidenced by our recent literature reviews and over
200 publications. To promote and facilitate continued progress, the NADIA Administrative Core is the main
organizational unit of the Consortium and serves as the liaison between the Scientific Core, the eight Research
Components, the NADIA Steering Committee, the External Advisory Board, and the NIAAA. The Administrative
Core organizes all Consortium activities including retreats, progress reports and External Advisory Board
evaluations of cores and components. The Administrative Core ensures consistent and forward progress by
facilitating communica-tion and promoting integration of data among the components and cores. The Core
develops scientific and conceptual themes as well as recommended operating procedures that cross
components. The Core provides a repository for all publications generated by the Consortium. Finally, the Core
facilitates dissemination and translation of NADIA-generated data, in part by targeted interactions with the
National Consortium on Alcohol and Neurodevelopment in Adolescence (NCANDA) and other alcohol research
groups. This NADIA renewal exactly fulfills the molecular mechanism and translation goals of this RFA leading
to development of therapeu-tic interventions of adult psychopathologies of adolescent alcohol consumption.
Understanding the impact of underage drinking on adult neurobiology is important to guide public health
initiatives, and the NADIA Adminis-trative Core creates synergies for such discoveries across the Consortium.

Public health relevance
PROJECT NARRATIVE Drinking in adolescence is common, but the persistent consequences of excessive drinking during adolescence are not well understood. The NADIA Administrative Core coordinates the efforts of eight Research Components and one Scientific Core to determine the consequences of binge-like adolescent alcohol exposure on adult brain physiology, structure, chemistry, maturation and behavioral indices of affect, motivation and/or cognition. This information will be important to guide public health policy and develop better tools for the prevention of risky behavior in adolescents.